Inter-CFAR Women and HIV Biennial Symposium

PROJECT SUMMARY/ABSTRACT
The goal of the Inter-CFAR biennial Women and HIV symposium is to share cutting edge research across the
national CFAR network and beyond, extend knowledge and foster action to address gaps toward
understanding the complex clinical, biologic and socio-behavioral aspects of HIV in cis- and transgender
women. In contrast to most other conferences, the symposium focuses on all aspects of HIV in the context of
women including structural and behavioral factors impacting their vulnerability while also serving as a venue for
highlighting the work of early-stage investigators including underrepresented minorities. Very few national
conferences feature representatives of these groups in such a prominent role, drawing together researchers
who may not otherwise have such opportunities. The format of the symposium enables dialogue among the
attendees to maximize the effectiveness of strategies to advance the field and promote mentoring and
development of early-stage and under-represented investigators. The symposium will continue to be a medium
that provides major support and opportunities for early-stage investigators and underrepresented minorities to
attend as participants through travel scholarships, to present oral and poster abstracts, and to engage in
mentoring activities, and networking sessions with senior leaders in the field. The 9th Inter-CFAR biennial
Women and HIV symposium will be hosted by the University of California, San Francisco (UCSF)-Bay Area
CFAR. The overarching theme of the 2023 symposium will be on “Women and HIV across the Lifespan” and
highlight three clinically significant and evolving areas of research: 1) Reproductive Health, in particular the US
Perinatal Guidelines on Breastfeeding with HIV: From Policy to Practice; 2) Antiretroviral Therapy and
Metabolism in the era of INSTIs: Sex and Gender Differences; and 3) Aging with HIV Across the Gender
Spectrum. Invited talks for session 1 will focus on the perspectives of leading HIV researchers in obstetrics and
pediatrics, and the patient. Sessions 2 and 3 will integrate cutting edge talks in basic, clinical, and social and
behavioral sciences. Panel discussions will be held at the end of each session’s invited talks followed by oral
presentations of selected abstracts in the theme of each session. Moderators to keep sessions on track and
guide panel discussions will be selected to ensure racial/ethnic and gender diversity and a range of
investigators from early career to senior for each session. The panels will clarify key questions and develop
future research strategies that will advance the field. Opportunities for informal networking between early
career and senior investigators in the field will be provided throughout the meeting including a reception with
the poster session on the first evening. These will be complemented by mentoring focused sessions during the
lunch breakout time that will highlight grant preparation advice, current NIH funding priorities and opportunities,
and CFAR-related resources available to facilitate women’s focused research. We anticipate similar outcomes
to past symposia including new collaborations, innovative approaches to research conduct, and advances in
career development.

Public health relevance
PROJECT NARRATIVE The goal of the Inter-CFAR biennial Women and HIV symposium is to share cutting edge research across the national CFAR network and beyond, extend knowledge and foster action to address gaps toward understanding the complex clinical, biological and social aspects of HIV in cis- and trans-women. In contrast to other conferences, the symposium focuses on all aspects of HIV in the context of women including structural and behavioral factors impacting their vulnerability while also serving as a venue for highlighting the work of early-stage investigators including underrepresented minorities.